Regulation of cocaine use by astrocyte voltage-gated channels

Project Summary/Abstract
Significant effort over the past decades has been devoted to uncovering neuronal mechanisms that regulate
substance use, including the use of cocaine. Notable progress in this effort includes evidence that dysregulation
of neuronal signaling after cocaine exposure may rely on plasticity within non-neuronal cells. A particularly large
share of attention has been paid to astrocytes, fueled by early demonstrations that a variety of brain insults from
trauma to neurodevelopmental disorders profoundly alter astrocyte morphology. Cocaine exposure impacts
astrocyte cytoskeleton, changing the size and shape of astrocyte cell bodies, processes, and proximity to
synapses. Additionally, cocaine triggers changes in the astrocyte ability to initiate and maintain propagation of
Ca2+ waves that have established themselves as a prototypical signature of “active” astrocyte signaling. Much
less is understood about cocaine effects on astrocyte K+ responses, a key feature of neuroglial interface whereby
astrocytes maintain ion homeostasis following neuronal extrusion of K+ ions during action potentials.
We provide the first, to our knowledge, evidence that astrocyte voltage-gated K+ channels are affected by and
contribute to cocaine use in the rat self-administration model. We present preliminary data that the voltage-gated,
KCNQ, channels in astrocytes of the nucleus accumbens shell (NAc) are rapidly and dose-dependently up-
regulated by extracellular dopamine, that KCNQ channel activity influences astrocyte Ca2+ responses after
cocaine self-administration, and that attenuation of cocaine-seeking by KCNQ inhibition requires functional NAc
astrocytes. We propose to use standard pharmacological techniques along with newer molecular approaches,
electrophysiology, and Ca2+ imaging to further describe astrocyte KCNQ channel contribution to cocaine use.
Our hypothesis is that KCNQ channels regulate astrocyte Ca2+ signaling to impact acquired cocaine-seeking
behavior as well as its reinstatement after extinction. Within this hypothesis, we define contribution of neuronal
activity, relevance of astrocyte Ca2+ compartmentalization to transmembrane and endoplasmic reticulum
domains, and cocaine impact on expression of KCNQ subtypes. We predict that astrocyte KCNQ activity,
independent of neuronal KCNQ channels, influences generation of intracellular Ca2+ signals by membrane-
proximal sources and that inhibition of astrocyte KCNQ activity pharmacologically or by virus-mediated knock-
down attenuates cocaine seeking and cue-induced reinstatement.
Results of this experimentation lay the foundation for investigating contribution of astrocyte K+ channels to
neuroglial coupling. For example, changes in astrocyte K+ may influence Ca2+ dependent release of
neurotransmitter molecules, cytokine production, and secretion of extracellular vesicles or other signals to
influence neuronal output and cocaine-associated behavior. Such studies will promote understanding of dynamic
roles of astrocytes in the healthy brain and facilitate novel cell-type specific approaches to mitigate cocaine use.

Public health relevance
PROJECT NARRATIVE CDC and SAMHSA data indicate that in 2021 there were about 500,000 new U.S. cocaine users aged 12 and older and that cocaine accounted for about 1 in every 4 drug overdose-related deaths. Development of novel therapies to address the challenge of new and on-going cocaine use depends on insights into the underlying biological changes within the brain of affected individuals, but prior research has focused overwhelmingly on how cocaine affects activity of neurons. This proposal explores new evidence that cocaine changes activity of astrocytes that are predicted to influence on-going cocaine use and relapse to use after abstinence.